Dissecting the role of GPR34 in cDC1 migration and function

PROJECT SUMMARY/ABSTRACT
As critical mediators of immunity against intracellular pathogens and cancer, type 1 conventional
dendritic cells (cDC1s) cross-present exogenous, cell-associated antigens to CD8+ T cells, facilitated by the
colocalization of these two cell types in the T cell zone of secondary lymphoid tissues. This microanatomical
organization is orchestrated by CCR7 and XCR1, two G protein-coupled receptors (GPCRs) on cDC1s that
guide their migration towards gradients of chemoattractant ligand. Recent reports have established a crucial
role for tumor-associated cDC1s in cancer immunity. However, the GPCRs mediating cDC1 recruitment and
positioning at sites of inflammation and in tumors are incompletely understood.
Preliminary work has revealed that GPR34, an understudied X-linked GPCR, is highly expressed by
cDC1s, and in vitro studies have shown that this lysophosphatidylserine (lysoPS)-responsive receptor supports
cell migration. Preliminary data presented herein indicate that GPR34 promotes the accumulation of cDC1s in
the inflamed mouse peritoneal cavity (PerC) in a cell-intrinsic manner. The PerC is a clinically important site for
colon and ovarian cancer metastasis. In a preliminary experiment inspired by the connection between cDC1
accumulation and cancer outcomes, GPR34-deficiency led to increased growth of a subcutaneous (SQ) tumor
model. This proposal will test the hypothesis that GPR34 regulates cDC1 organization and function
during inflammation and cancer. Aim 1 will mechanistically define how GPR34 controls the abundance,
trafficking, and positioning of PerC cDC1s using a combination of techniques including in vivo kinetic immune
phenotyping, in vitro migration assays, and immunofluorescence microscopy. Aim 2 will investigate the role of
GPR34 and lysoPS in cancer immunity using ectopic SQ and PerC tumor models along with tools to study
antigen-specific T cell responses and to manipulate ligand levels. Completion of these Aims will elucidate key
mechanisms by which GPR34 on cDC1s influences the response to inflammation and malignancy, providing
opportunities for the development of therapeutics that modulate the lysoPS-GPR34 chemoattractant system.
These research goals will be conducted in conjunction with a comprehensive training plan to prepare
the applicant for an independent career as an academic physician-scientist. Training includes rigorous
mentorship in scientific skills from a highly qualified sponsor, Dr. Jason Cyster; technical education from
postdoctoral fellows in the applicant’s lab and collaborating labs; seminars, journal clubs, workshops, and
conferences; and clinically geared activities. Research and training will take place at the University of
California, San Francisco, which offers a highly innovative and collaborative immunology research environment
and an exceptional medical school for clinical training.

Public health relevance
PROJECT NARRATIVE Type 1 conventional dendritic cells (cDC1s) are critical for the generation of effective immune responses against intracellular pathogens and tumors, but how cDC1s localize to sites of immune insult is incompletely understood. We have found that GPR34, an understudied G protein-coupled receptor, can cell-intrinsically promote cDC1 accumulation and that the receptor can suppress the growth of implanted tumors. This proposal builds off these preliminary data to mechanistically dissect how GPR34 controls cDC1 migration, positioning, and function during inflammation and cancer.